2025 Antimicrobial Peptides Gordon Research Conference and Seminar

Project Summary
The Gordon Research Conference (GRC) on Antimicrobial Peptides (AMPs) in 2025 will convene at the Four
Points Sheraton / Holiday Inn, Ventura (CA), USA from Feb 23-28, 2025. This successful series of GRCs has
been driving new interdisciplinary thinking on innate immunity since its inception in 1997. It is held every other
year and is recognized as the premier meeting of this field. AMPs are found across all domains of life and critical
in resolving infections, controlling microbiota, and contributing to diverse host functions. The GRC program is
divided into lecture sessions and poster sessions. One important objective of the 2025 conference is to promote
an integrative view of AMP roles in the immunity and physiology of organisms by bringing together scientists
from different AMP communities that often evolve separately. We expect this to propel the field in cross-cutting
directions by leveraging recent interdisciplinary knowledge. The themes of sessions have been designed
accordingly. The conference will begin with new research on the multiple functions of AMPs. A keynote lecture
by Tomas Ganz, one of the founders of the field, an internationally renowned chair of the first GRC conference
on AMPs, will present a remarkable example of this multifunctionality. Additionally, this opening session will
illustrate the diversity of new AMP functions through two recent discoveries. Other sessions also include AMP
discovery and design, interactions of AMPs with antibiotics, AMP in the biology and ecology of microbes, AMPs
in infectious diseases, AMPs in non-infectious diseases, evolution of resistance to AMPs. Short talks will be
selected from key posters, with attention to include junior and student level scientists, as well as scientists from
the different genders and underrepresented minority populations that encompass ethnicities and other diverse
attributes. Ample time for organized discussion and informal interaction amongst participants will be included.
We will have a Power Hour™ with two women Chairs designed to address issues of women in science, diversity
and inclusion, in an open forum for discussion and mentoring. An innovative aspect of this meeting is the pre-
conference forum for graduate students and post-docs to exchange new data and ideas in a comfortable setting
of peers (GRS). As with past meetings in this GRC series, the 2025 conference promises to provide a unique
forum for deep scientific exchange on the fundamental biology of AMPs in immune functions and resolution of
infections, in their diverse therapeutic applications, and in the larger biology of AMPs in the host across multiple
kingdoms of life.

Public health relevance
PROJECT NARRATIVE The Gordon Research Conference and Seminar on Antimicrobial Peptides will assemble a diverse interdisciplinary group of scientists for in-depth discussions on antimicrobial peptides, which are critical in the control of infections, and a wide range of physiological functions in the host across different kingdoms of life.